Depict the cell fate map of pulmonary angioblast

ABSTRACT
Endothelial cells are vital for maintaining homeostasis and facilitating repair following vascular injury or disease.
Vascular regeneration is increasingly recognized as critical for treating vascular diseases, with recent evidence
highlighting the role of resident angioblasts. Despite their importance, the cellular characteristics and regulatory
mechanisms governing angioblasts remain poorly understood. This project seeks to bridge this gap by leveraging
existing scRNA-seq data to explore the trajectory of pulmonary angioblasts (PACs), their derived cells, and the
molecular markers and signaling pathways that drive their differentiation and function. As such, this proposal
aligns perfectly with the NIH PAR-23-036 funding opportunity, which supports the reanalysis of existing data to
address critical gaps in knowledge. By reanalyzing these datasets, we will uncover novel insights into PAC
identity, fate, and the regulatory mechanisms driving their function. This approach allows us to address important
questions in pulmonary vascular biology with minimal experimental burden, maximizing the utility of existing data
while advancing our understanding of vascular development. Our preliminary analyses of available scRNA-seq
datasets have identified PACs with significant self-renewal capacity in mouse lungs, peaking between embryonic
day 12.5 (E12.5) and postnatal day 7 (P7). Intriguingly, trajectory analysis reveals that PACs do not directly
differentiate into mature endothelial cells (ECs) such as arterial ECs (aECs), venous ECs (vECs), or capillary
ECs (C2-ECs). Instead, PACs differentiate into an intermediary population of CD34high cells (C1-ECs),
subsequently generating other EC subtypes. Underscoring their importance, PACs and their progeny were
significantly reduced in hyperoxia-induced bronchopulmonary dysplasia (BPD) mice, which have arrested
pulmonary vascular development and alveolarization. We have identified several major knowledge gaps in our
understanding of pulmonary vascular development. a) How vasculogenesis, intussusceptive and sprouting
angiogenesis are coordinated with lung development remains unclear. b) The spatial-temporal lineages of EC-
related cells during lung development and regeneration are unexplored. c) The functional roles of different
lineages in lung development and homeostasis are not well defined. d) The specificity of the PACs vs angioblasts
from blood island during the embryo stage in mice. e) The regulatory mechanisms guiding PAC cell fate and
localization are largely unknown. The previous findings about pulmonary vascular development and our
preliminary data lead us to hypothesize that PACs are crucial for pulmonary vasculature development by
residing in specific niches that facilitate lung development. PACs have the most robust self-renew ability.
In proximal regions, PACs localize along arterial and venous vessel walls to contribute to
intussusceptive angiogenesis. In distal regions, PACs differentiate into CD34high cells and lead the
protruding into secondary septa, which form neovasculature and promote the alveolar-capillary
structure. (Fig. 1). To test this hypothesis, we propose two specific aims. Aim 1: Define PAC cell identity, cell
fates, and regulatory mechanisms in mice and humans. Aim 2: Visualize PAC and PAC-derived cell lineages
during development and vessel injury.

Public health relevance
Narrative This proposal aims to define pulmonary angioblasts’ identity, cell fate, and regulatory mechanisms, highlighting their specific niches and contributions during pulmonary vascular development. Our findings will advance therapeutic strategies for promoting vascular regeneration.